Learning Health systems training to improve Disability and chronic condition care (LeaHD) Research and Data Analysis Core

ABSTRACT: RESEARCH AND DATA ANALYSIS CORE
The overall objective of the RDAC is to ensure that our LHS scientists, in collaboration with our health system
partners, are generating and disseminating high quality, relevant, and impactful evidence to improve health
system operations, quality of care, and health outcomes for individuals and populations with disability and
chronic conditions. To achieve this objective, the RDAC proposes the following specific aims to support its LHS
scientists and their teams and to support the Center as a whole:
Aim 1: Provide services, tools, and resources to promote best practices for patient-centered outcomes
(PCOR), comparative effectiveness (CER), and dissemination and implementation (D&I) research within
learning health systems (LHSs).
Aim 2: Provide guidance on the regulatory, data use and management, and data sharing issues associated
with conducting partnered (e.g., academic & health system) research and quality improvement activities within
LHSs.
Aim 3: Assist in the dissemination and implementation of the scientific information and evidence created by the
Center’s LHS scientists.
The RDAC will contribute to the professional growth and development of LHS scientists and enhance the rigor
of scientific projects developed in conjunction with learning health systems partners. RDAC will assist LHS
scientists as they develop meaningful research questions; navigate the regulatory, governance, and data
complexities of conducting research in learning health systems; and produce high quality, relevant, and
impactful evidence that will advance the quality of care and health outcomes for individuals and populations
with disability and chronic conditions.